Implementing sustainable evidence-based mental healthcare in low-resource community settings nationwide to advance mental health equity for sexual and gender minority individuals

PROJECT SUMMARY
Background. Sexual and gender minorities (SGM) experience among the largest mental health disparities of
any population, at substantial cost to society. One driver has been the lack of evidence-based practice (EBP)
addressing the distinct mechanisms underlying SGM's risk. For 10+ years, our team has developed LGBTQ-
affirmative cognitive-behavioral therapy (CBT) as the first and only EBP specifically for SGM mental health,
now in high demand. This proposal seeks to study optimal means of implementing this effective treatment at
LGBTQ community centers nationwide to advance implementation science and health equity. Pilot Studies.
Our pilot data across 50 LGBTQ community centers shows that (1) training can improve providers' LGBTQ-
affirmative CBT skills, (2) directors of LGBTQ centers unanimously support this training, (3) providers perceive
that ongoing supervision can help maintain implementation but that receiving learning materials is also
invaluable. Still, knowledge gaps remain for implementation science, including: (1) whether train-the-trainer
strategies can further sustain implementation, (2) whether features of low-resource settings (e.g., high staff
turnover) predict optimal implementation strategies, and (3) the target mechanisms through which EBP training
impacts implementation and client outcomes. The proposed research will answer these questions. Method.
Drawing on our long-standing partnership with the US's coordinating hub of LGBTQ community centers, in this
type 3 hybrid trial we will randomize 90 centers to receive one of three strategies for implementing LGBTQ-
affirmative CBT to compare their effectiveness (Aim 1), identify center-level moderators of implementation
success (Aim 2), and examine the impact of the three strategies on client mental health through theory-
informed organizational and provider mechanisms (Aim 3). Drawing on social learning theory, mental health
research in low-resource settings, and our pilot data, we will compare three implementation strategies: (1) a
suite of digital learning materials (materials only condition); (2) these materials plus weekly webinar training for
12 weeks (direct training condition); or (3) the above plus 1-year of supervision from a local supervisor who will
receive expert consultation in a train-the-trainer format (local supervision condition). Implementation outcomes
will include objectively coded provider fidelity in LGBTQ-affirmative CBT and mixed methods assessments of
its reach, adoption, and maintenance across centers. Effectiveness outcomes will include client depression
symptoms. Hypotheses. We hypothesize that the three additive training strategies will predict respective
graduated increases in implementation success up to 2 years post-training. We hypothesize center-level
determinants of implementation success from the Consolidated Framework for Implementation Research. We
hypothesize organizational and provider factors that will mediate the stronger impact of the more intensive
training strategies on implementation success and client mental health. Dissemination. We will distribute
scenario-based recommendations and budget impact to encourage maintenance across US LGBTQ centers.

Public health relevance
PROJECT NARRATIVE Although sexual and gender minorities (SGM) experience among the largest mental health disparities of any population, evidence-based mental health practice specifically targeting this population's distinct stressors and stress responses has been unavailable until recently. Now that LGBTQ-affirmative CBT has shown effectiveness across several trials and generated high demand, implementation science is needed to determine optimal nationwide implementation strategies. This study will identify optimal means through which to implement this treatment innovation in the US's large network of LGBTQ community centers, thereby producing generalizable guidance for EBP implementation across low-resource settings nationwide in which mental health disparities populations are likely to seek treatment.